IGF::OT::IGF: SBIR Phase I Award for A System for the Specification of Acute THC Impairment Using Validated Algorithms Period of Performance 09/30/2018 to 03/30/2019

Under this Small Business Innovation Research (SBIR) Phase I project, Research Topic 163, the Contractor will develop a portable, easily applied system incorporating a neuropsychological test protocol to detect cannabis impairment.